Particulate matter-induced changes in DNA methylome and transcriptome

? DESCRIPTION (provided by applicant): Particulate matter (PM) air pollution is a global environmental health problem that causes 3.7 million premature deaths annually, representing 6.7% of all deaths worldwide. These deaths are largely due to increased acute cardiopulmonary disease. Although efforts to abate PM levels led to reduction in PM-induced morbidity and mortality, the association between PM and cardiopulmonary disease still persists. There is need for early identification of individuals who are at risk for PM-induced cardiopulmonary disease to reduce the burden of disease further. Exposure to PM is associated with epigenetic modifications of DNA such as DNA methylation (5mC) and hydroxymethylation (5hmC) that regulate gene transcription. Assessment of these epigenetic changes may help with the identification of individuals at risk for development of PM-induced cardiopulmonary diseases. Increasing number of studies demonstrate that PM induces epigenetic changes but the implications of these findings are limited because these studies focused on the methylation patterns of the repetitive elements without detailed analysis of the whole genome. Furthermore, the studies were done in surrogate cells such as blood leukocytes and nasal epithelial cells without any correlation in target tissues. It is not known whether changes in DNA methylation or hydroxymethylation in peripheral blood monocytes can also be found in the target tissue or cell such as lung epithelial cells, alveolar macrophages or aortic endothelial cells. In preliminary studies, we found that PM treatment caused epigenetic changes characterized by reduction in 5mC and increased 5hmC in nasal and lung epithelial cells and alveolar macrophages. In addition to epigenetic changes, PM induced similar expression of some genes and differential expression of others in primary human nasal and lung epithelial cells ex vivo and in a murine model of PM exposure in vivo. PM-induced changes in gene expression and DNA methylation in primary human nasal epithelial cells were different among individuals as well as between males and females suggesting an important role for host-related factors such as genetics, age and sex in influencing the PM-induced responses. Based on our preliminary data, we hypothesized that changes in DNA methylation and hydroxymethylation and the gene expression (RNA-seq) in surrogate cells (nasal epithelial cells and peripheral blood mononuclear cells) can be used to predict those changes in target tissues (lung epithelial cells, and macrophages, heart and aorta). Using a clinically relevant murine model of PM exposure via inhalation, in Aim 1, we will determine the how PM-induced changes in DNA methylome and transcriptome differ in surrogate (nasal epithelium, and peripheral blood monocytes) and target cells (alveolar epithelial cells, macrophages, heart and aorta). In Aim 2, we will determine whether the host related factors (strain, sex and age) affect PM-induced changes in DNA methylome and transcriptome in surrogate and target cells and in Aim 3, we will determine whether the PM-induced changes in DNA methylome and transcriptome in surrogate and target cells persist throughout the lifespan.

Public health relevance
PUBLIC HEALTH RELEVANCE: Particulate matter air pollution causes a global environmental health problem that causes 3.7 million premature deaths per year worldwide. Exposure to particulate matter causes changes in epigenetics (biological mechanisms that switch genes on and off), which play an important role in the development of disease. In this application, we will determine the pattern of epigenetic changes and gene expression induced by particulate matter in surrogate tissues and cells such as nose and blood cells and correlate these changes with those in target tissues such as lungs, heart and aorta.